Integrating a suicide prevention package of strategies into decentralized primary health care systems: an implementation pilot study in rural Nepal

PROJECT SUMMARY/ABSTRACT
Suicide is a leading contributor to global mortality and rates have remained steady, or increased, in low-
resourced settings. South Asia has the highest suicide rate in the world and despite different cultural risk profiles
for suicide, little research has explored strategies for health systems to address its growing suicide burden. Given
rising suicide rates and growing dissemination of mental health training programs for primary care health workers
to treat common mental disorders (the WHO mental health gap action programme, mhGAP), there is critical and
urgent need to incorporate implementation strategies for suicide detection, management and follow up within
these programs. Community health workers remain an untapped resource to provide suicide prevention support
in settings where it is needed most, particularly within overburdened health facilities. Using co-design principals
and RE-AIM with primary health workers and a community advisory board, this project will assess barriers to
implementing mhGAP suicide modules, then adapt and pilot test a package of strategies to optimize
implementation within a decentralized primary care system in Nepal. We anticipate the primary care suicide
prevention package (P-SuPP) will include more systematized screening with decision tool aids, the systematic
integration of CHW task-shifted safety planning and contact follow-up, supportive supervision, and enhanced
digital monitoring systems. The proposed research will in Aim 1 conduct a formative evaluation of current mhGAP
suicide practices among clinicians and then co-develop and refine implementation protocols (including
workflows, health worker training, and support standards) for integrating suicide detection and follow-up
management (P-SuPP) to meet the needs of primary health providers. Aim 2 will complete a pilot feasibility
hybrid type 2 randomized controlled trial (RCT) of P-SuPP versus standard mhGAP. We will use mixed-methods
to assess trial feasibility and acceptability of implementing and sustaining P-SuPP. We will explore patient-level
preliminary effectiveness outcomes including suicidality, depression, and uptake of follow-up care. We will also
explore preliminary pilot RCT implementation outcomes including Reach, Adoption, Implementation, and
Maintenance of P-SuPP at 6 months for a future fully powered trial. This R34 lays the groundwork for a future
R01 to scale a package for suicide prevention strategies that can be integrated into government primary care
facilities, particularly targeting individuals living in low-resourced settings. As the model is designed to be easily
adapted and integrated, we anticipate the findings will be valuable for all researchers looking to improve
population health and mental health services in disadvantaged settings.

Public health relevance
PROJECT NARRATIVE South Asia has the highest suicide rate in the world with important risk profile differences from high-income settings. We will conduct formative research to identify barriers and facilitators to uptake and fidelity of suicide module of the mental health gap action programme and adapt a package of strategies to optimize its use in primary care health facilities to test in a pilot feasibility cluster randomized controlled trial in Nepal. Potential health impacts may be substantial as results can be applied not only in similar South Asian primary healthcare contexts, but also in low-resource settings in the US and abroad, where the suicide burden remains high.